Mechanisms and functions of lipid recycling for cellular metabolism

Project Summary/Abstract
My lab seeks to address mechanisms of cellular fatty acid metabolism and their implication in cellular functions.
Subcellular organelles called lipid droplets (LDs) play an integral role in lipid metabolism by storing lipids and
buffering cellular fatty acid fluctuation to prevent lipotoxicity and to adequately provide lipid sources as needed.
Much effort has focused on defining and elucidating the pathways governing LD formation, but less is known
about how fatty acids are released from LDs in (patho)physiological circumstances. A major long-term goal of
our research program is to understand how cells regulate fatty acid recycling pathways to control metabolism
and signaling in health and disease. In the next five years, we will focus on two areas outlined in this proposal:
1) What are the regulatory mechanisms underlying the autophagic lipid degradation pathway? Lipophagy is a
critical cellular pathway that degrades LDs to supply lipids for cellular functions. We recently discovered a specific
lipophagy receptor, a crucial first step toward revealing the mechanisms of this pathway and its contribution to
cellular lipid metabolism. Building on this foundational discovery, my lab will investigate the cell states and
metabolic conditions in which the lipophagy pathway participates and its mechanistic foundations.
2) How are lipids trafficked within cells and utilized at inter-organelle membrane contact sites? Lipids recycled
from LDs are essential for various cellular functions, including membrane biogenesis, energy production, and
signal transduction. However, the process of how fatty acids traffic and find their destinations in cells remains
elusive. My lab will elucidate how LDs crosstalk with various subcellular organelles to efficiently transfer lipids
and support cellular metabolism.
Our proposed research will reveal fundamental principles of lipid recycling mechanisms and contribute to the
development of potential therapeutic strategies focused on defective lipid metabolism in various metabolic and
neurodegenerative disorders.

Public health relevance
Project Narrative The lipid droplets are important organelles for fatty acid homeostasis whose dysregulation is causative of many metabolic diseases, including diabetes, numerous cancers, and cardiovascular diseases. The goal of this project is to understand the cellular mechanisms that regulate the recycling of fat and its impact on cellular energy homeostasis. Completing these studies will significantly advance our understanding of the molecular control of fat catabolism and may lead to new therapeutic approaches for various lipid storage diseases.